Computer Simulations of Enzymes

Project Summary
Our first research theme is the accurate and efficient description of bio-molecular interactions,
which is at the core of biological modeling, particularly for the understanding of protein structures
and the reactions catalyzed by enzymes. Achieving optimal results requires an energy function
that balances accuracy with computational efficiency, in both quantum mechanical (QM) methods
and the molecular mechanical (MM) force fields.
The second theme is to study and reveal the complex reaction mechanisms of key enzymes.
Enzymes are biological catalysts that drive biochemical reactions essential for life. Studying
reaction mechanisms in enzymes is crucial for obtaining insights into fundamental biological
processes, developing inhibitor and drug, aiding in the development of diagnostic tests and
prognostic tools for diseases, optimizing biomedical technology, and inferring evolutionary
relationships. This proposed MIRA research project focuses on three directions.
(A) Developing QM methods based on density functional theory (DFT) to achieve accuracy
and efficiency needed for biological systems. DFT is the most widely used QM for biological
molecules. Despite its success, DFT can still suffer from large pervasive systematic errors. We
will develop the localized orbitals scaling corrections to eliminate these errors.
(B) Constructing protein and biomolecular force fields based on multiscale QM and MM and
machine learning (ML). Although MM force fields have been successfully applied to many
problems, they still frequently fail to capture the correct conformational and energetic features of
diverse biomolecules. We will build on the residue-based systematic molecular fragmentation
(rSMF) approach developed in the PI lab to develop a general and scalable ML force field for all
biomolecules based on QM/MM and rSMF, providing a unified model for not only proteins, but
also protein-ligands, RNA-ligands, and other complexes.
(C) Investigating reaction mechanisms of 5’-deoxyadenosyl radical formation in radical SAM
enzymes. Radical S-adenosylmethionine (SAM) enzymes form one of the largest enzyme
superfamilies with more than 700,000 unique sequences. They are abundant in Nature, involving
in many medically important pathways. We will characterize the mechanism of SAM cleavage
using MoaA radical SAM enzyme as a model system, in collaboration with experimental efforts.
The plan research, harnessing the latest QM, QM/MM and ML developments, will advance
simulation methods for biological systems and provide valuable insights into enzyme functions.

Public health relevance
Project Narrative The study of structure and functions of proteins and enzymes is crucial as it sheds light on the fundamental processes and enables the advancement of new or improved inhibitors and enzymes. Aiming to gain a deeper understanding of the structure-function relationship and the catalytic role of enzymes, this proposal focuses on advancing simulation methods for investigating the structure, dynamics, and chemical processes in proteins, specifically targeting the MoaA enzyme, a critical S-adenosyl-L-methionine (SAM) enzyme. By developing general computational approaches and uncovering the mechanisms of MoaA, we can significantly improve research tools for studying enzymes, deepen our understanding of life processes, and assist in the development of effective inhibitors and drugs.